MAGNESIUN THERAPY FOR HEART RATE CONTROL IN CHRONIC ATRIAL FIBRILLATION

It is the purpose of this study to determine the effects of acute intravenous magnesium dosage on the heart rate response to exercise in a group of patients with atrial fibrillation of various etiologies. Two groups, with 10 subjects each, will serve as their own controls in determining whether the acute and/or chronic magnesium therapy blunts the heart rate response to exercise in atrial fibrillation.